Developing Patient-Centered Decision Support for Eosinophilic Esophagitis

PROJECT SUMMARY
Candidate’s Long-term Career Goal: To become an independently funded physician-scientist developing
and testing patient-centered interventions to support shared decision making (SDM) in chronic esophageal
diseases.
Research Context: As a chronic disease with rapidly rising prevalence, incidence, healthcare costs, and
burdens to patient quality of life, eosinophilic esophagitis (EoE) is an understudied, challenging area of care for
both patients and providers that requires support in education, decision making, and communication around
complex treatment choices to prevent costly complications. As clinical equipoise exists between medication
and dietary therapies, understanding stakeholder drivers of decision making and applying SDM are critical
gaps in patient-centered EoE care, and are needed to improve long-term disease outcomes.
Candidate Background and Achievements: Dr. Chang is an Instructor in Gastroenterology at the University
of Michigan (UM) and an awardee of a Consortium of Eosinophilic Gastrointestinal Disease Researchers grant.
She received her MD from the University of Maryland and MS from UM. To date she has published 13 original
peer-reviewed manuscripts and one book chapter, 10 of which she is first or senior author.
Career Development Plan: Dr. Chang proposes to develop new expertise in mixed methods, advanced
qualitative research methods, decision sciences, and clinical trial conduct and evaluation to assess the impact
of a decision support intervention on outcomes. Her career development goals are supported by stellar
mentorship, advanced didactic coursework, and participation in workshops and professional meetings
designed to foster collaboration, ensure successful study completion, and support her seamless transition into
a successful independent researcher.
Aims: 1) Elicit the multilevel factors that influence decision making for EoE management among patients and
providers, 2) Develop a multilevel decision support intervention prototype that supports SDM for selection of
EoE therapy, and 3) Pilot test and evaluate feasibility, acceptability, and preliminary patient-reported efficacy
outcomes associated with use of the decision support intervention.
Research Plan: Dr. Chang will 1) use a mixed methods design to interview patients with EoE to identify factors
that drive treatment decision making, 2) conduct qualitative interviews of gastroenterologists and allergists to
characterize provider perspectives about EoE management and supported decision making, 3) develop a
multilevel decision support intervention to facilitate SDM between patients and providers, and 4) assess
decision intervention feasibility, acceptability, and influence on preliminary efficacy outcomes comparing 20
patients receiving decision support to 20 patients receiving control content.

Public health relevance
PROJECT NARRATIVE Eosinophilic esophagitis (EoE) is an understudied chronic inflammatory disease with increasing prevalence, incidence, healthcare costs, and burdens to quality of life. As clinical equipoise exists between effective medication and dietary therapies, complex decision making around treatments and chronic disease management is challenging for patients and providers, and understanding the drivers of decision making and applying shared decision making are critical gaps in patient-centered EoE care. This proposal aims to leverage patient and provider experiences and preferences to develop and test a multilevel decision support intervention that will help patients with EoE and their physicians share information to support informed decision making in selecting treatments.